Engineering Surface Coatings for Localized Delivery of Therapeutic Extracellular Vesicles

PROJECT SUMMARY
The PI’s long-term research goal is to engineer the cell-material interface for applications in tissue engineering,
regenerative medicine, and medical implants, with a particular focus on bone regeneration. Extracellular vesicle
(EV) - based therapies have been of increasing interest in the past decade to treat a variety of pathologies.
Although EV delivery from various carrier systems has been shown to induce tissue regeneration in preclinical
models, there remains a critical gap in efficient and controlled delivery of therapeutic EVs. This proposal aims to
engineer a surface coating system that promotes localized EV delivery for tissue engineering and regenerative
medicine applications. The central hypothesis underlying this research is that surface-mediated EV delivery
modulates cellular uptake and signaling in comparison to bolus or systemic EV delivery.
The specific research objectives of this proposal are to: (1) Investigate the roles of electrostatic and receptor-
ligand interactions in the adsorption and release of EVs to/from surface coatings; (2) Investigate the effects of
surface-based EV delivery in comparison to bolus EV delivery; and, (3) Demonstrate that EV delivery from
surface-coated tissue engineering scaffolds improves tissue regeneration in vivo in a rat spinal fusion model. EVs
will be derived from mesenchymal stem/stromal cells (MSCs) and characterized for size, surface charge, and
protein markers. Interactions between MSC-EVs and surface coatings composed of ECM proteins,
polysaccharides and charged polymers will be analyzed under various conditions (pH, R-L inhibitors, salt
screening) via fluorescence labeling studies and quartz crystal microbalance with dissipation analyses. EV uptake
efficiency and endocytic pathways will be analyzed in several cell types (MSCs, HUVECs, HEK293s) in
comparison to bolus EV delivery via fluorescence microscopy and flow cytometry (+/- endocytic pathway
inhibitors). Cellular adhesion, proliferation, and angiogenic differentiation and immunomodulation will also be
analyzed in vitro. In vivo bone forming capacity and fusion efficacy of EVs delivered from surface-coated
scaffolds will be evaluated in the rat posterolateral lumbar fusion model via manual palpation, radiographic
scoring, volumetric microcomputed tomography (µCT) and immunohistochemistry, in comparison to uncoated
scaffolds and bolus delivery. Results from this work will significantly advance understanding of how material
properties and surface-based EV delivery impact cellular EV uptake, adhesion, proliferation and differentiation.
Additionally, this proposal will enable development of effective therapeutic EV surface-coatings that can tailored
for a wide variety of scaffolds and/or implants for many different therapies, including cartilage regeneration,
diabetic wound healing, cardiac infarction, and tendon and muscle repair.

Public health relevance
PROJECT NARRATIVE Recent research has shown that extracellular vesicles (EVs) derived from mesenchymal stem/stromal cells (MSCs) can successfully induce regeneration in many tissues and organs in animal models. However, there remains a critical gap in efficient and controlled delivery of therapeutic EVs for clinical translation. Findings from these studies may enable the engineering of effective therapeutic biomaterial EV surface-coatings that can be tailored for a wide variety of medical implants for many different clinical tissue repair and regeneration therapies.